Alternative Pathway of Complement Activation in Age-Related Macular Degeneration

DESCRIPTION (provided by applicant): The long-term goal is to understand the fundamental basis of complement signaling in the eye, and how misregulation in this process leads to pathology, to ultimately aid in the development of therapeutic approaches for devastating blinding diseases. Age-related macular degeneration (AMD) occurs in two forms, dry and wet. Dry AMD is characterized by drusen, RPE damage, and photoreceptor cell loss. In some patients, the dry form can transition to wet AMD. Wet AMD, presents itself with chroidal neovascularization (CNV), leakage of these new vessels, and rapid photoreceptor loss. Recent genetic evidence has implicated variations in the complement inhibitor protein factor H (CFH), as well as in the genes for complement factor B (CFB), C2 and C3, as potential risk factors for the disease. A common environmental stressor in AMD is oxidative stress. Three pathways activate the complement system: the classical (CP), alternative (AP), and mannose- binding lectin pathway (LP);all three converge on the same down-stream cascade. Experiments from our own laboratory as well as others, using the laser-damage model of CNV, have suggested that AP signaling is required for CNV development;whereas conflicting evidence has been published in the involvement of the other pathways. AP activity was found to control the generation of the proangiogenic factor vascular endothelial growth factor (VEGF), required for triggering new vessel growth. Finally, we have shown that AP activation is involved in oxidative stress-mediated RPE dysfunction characterized by VEGF and MMP release from RPE monolayers. Oxidative stress was found to sensitize the RPE to complement attack by reducing the levels of membrane-bound endogenous complement inhibitors. For this proposal we will be guided by our overall hypothesis that pathologic activation of the AP has direct effects on the RPE, generating a permissive cellular environment for AMD pathology. This hypothesis will be tested in three aims, both in vivo as well as in RPE cultures (primary human and mouse RPE cells). Using mice in which different pathways of the complement cascade are disrupted and complement-depleted serum, we will examine the relative roles of complement activation mechanisms and determine whether AP activation is required or sufficient. To identify the source of AP proteins (i.e., liver or eye), tissue-specific transgenic mice are analyzed. Next, we will test whether complement activation is specific for CNV, or whether AMD pathologies related to oxidative stress in the Sod1-/- mouse require a hyperactive complement cascade for them to develop. Experiments will be performed to test whether VEGF is involved in mechanisms of complement-mediated injury. And finally, the hypothesis will be put to test in vivo. We will use complement inhibitor strategies using targeted inhibitors that block the complement cascade at different levels to interfere with CNV. Testing inhibitors will not only establish their therapeutic value, but in addition, elucidating their mechanisms in CNV mice will investigate the roles and contributions of the different complement components in CNV. PUBLIC HEALTH RELEVANCE: Age-related macular degeneration (AMD) involves activation of the alternative pathway (AP) of complement and oxidative stress. We are investigating in both an animal model of AMD as well as in retinal pigment epithelial cells (RPE) monolayers how the pathologic activation of the AP, possibly facilitated by oxidative stress, causes direct cellular injury, triggers choroidal neovascularization (CNV), one of the hallmarks of wet AMD, and induces the RPE to secrete factors that promote AMD. Our current research suggests that complement inhibitors may be very effective therapeutic agents, as they target proximal events prior to inflammation and CNV.

Public health relevance
Age-related macular degeneration (AMD) involves activation of the alternative pathway (AP) of complement and oxidative stress. We are investigating in both an animal model of AMD as well as in retinal pigment epithelial cells (RPE) monolayers how the pathologic activation of the AP, possibly facilitated by oxidative stress, causes direct cellular injury, triggers choroidal neovascularization (CNV), one of the hallmarks of wet AMD, and induces the RPE to secrete factors that promote AMD. Our current research suggests that complement inhibitors may be very effective therapeutic agents, as they target proximal events prior to inflammation and CNV.